Characterizing the Effect of Altered CSF and Blood Flow Dynamics on Alzheimer’s Disease Proteinopathy, Brain Health, and Cognition

ABSTRACT
Although the brain lacks a traditional lymphatic system for clearing waste products, it has been hypothesized
that the brain possesses alternative pathways such as the glymphatic system and intramural periarterial
drainage. Recent experimental evidence in Alzheimer's disease (AD) models suggests clearance of amyloid
beta from the brain occurs along these pathways. These pathways are driven by cardiac pulsations and
vasomotion which induce cerebrospinal fluid (CSF) flow dynamics and brain tissue motion. Cerebrovascular
disease (CVD), has a strong link with both mild cognitive impairment and AD dementia, and there is potential
that CVD modulates waste clearance. However, the interactions between blood flow and CSF flow dynamics in
humans are understudied and their relationship to underlying pathophysiology of AD has only recently begun
receiving attention. To provide insights into CVD-AD relationships, non-invasive Magnetic Resonance Imaging
(MRI) is being utilized in longitudinal studies of AD risk-enriched populations. MRI methods commonly employed
today such as fluid attenuation (e.g. white matter hyperintensities) and susceptibility imaging (e.g.
microhemorrhages) only indirectly evaluate CVD and cannot inform on the dynamic vascular motion and
hemodynamic phenomena that have been indicated in animal models to affect AD pathology. The present study
applies previously develop MRI techniques to AD that are sensitive to blood and CSF flow dynamics. Recently,
we have successfully use non-invasive 4D-Flow MRI to characterize cerebrovascular health in the context of
AD. Using 4D-Flow MRI significant cerebrovascular changes were found in clinically diagnosed AD subjects
when compared to cognitively normal. These changes included increased intracranial vessel stiffness and
reduced vasomotion; however, hypothesis testing of CVD-AD interactions from these studies was limited by the
lack of CSF flow and AD biomarker data. In this project, we propose using 4D-Flow MRI for the quantification of
blood and CSF flow dynamics in addition to the integration of AD biomarker data. The vascular biomarkers will
be studied in preclinical and impaired AD subjects and correlated with longitudinal amyloid and tau (from CSF
assays and PET) measures. Such data will drive hypothesis testing on the modifying effect of vascular alterations
on the symptom expression of cognitive impairment, AD biomarker accumulation, and brain health. Participants
targeted for this study have extensive existing AD biomarker data and are being followed longitudinally through
studies within the Wisconsin Alzheimer's Disease Research Center. Upon completion of this study, we will have
a better understanding of the impact of intracranial vessel stiffness and CSF pulsatility on Aβ42/ Aβ40 ratios (an
indicator of amyloid brain clearance) and the interacting effect of intracranial vessel stiffness and amyloid on AD
pathology accumulation, brain health and cognition. Additionally, we would have collected preliminary data and
rationale to submit a larger extramural application (e.g. NIA/NIH R01) to support studies focused on
understanding the role of cerebrovascular health on AD pathology and AD related dementia.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease co-occurs with vascular disease; however, the nature and mechanism by which these diseases interact to develop clinical dementia remains relatively unknown. Using dynamic MRI techniques this project enables new insights into vascular health. The overarching objective is to characterize cerebrovascular involvement in Alzheimer's disease through the study of blood and CSF flow interactions with cognition, AD pathology and metrics of brain health.